Clarifying the association of depressive symptoms with cortico-limbic tau, cerebral blood flow, neurodegeneration, and longitudinal cognitive decline in individuals with mild cognitive impairment

Project Summary
Symptoms of depression, including mild subsyndromal symptoms of depression (SSD) and more severe Late
Life Major Depression (LLD), are among the strongest predictors of accelerated cognitive decline and have been
associated with up to a 4-fold increased risk of dementia. However, studies linking depressive symptoms to
amyloid-β (Aβ), neurodegeneration (brain volume), and measures of cerebrovascular disease (white matter
hyperintensities; WMH) in older adults have not sufficiently explained accelerated cognitive decline in these
individuals. There is now compelling evidence to suggest that greater spread and accumulation of
hyperphosphorylated tau protein (neurofibrillary tangles) is more strongly associated with depressive symptoms
than Aβ deposition and is likely also a significant factor contributing to cognitive dysfunction and cognitive decline
attributed to depressive symptoms in older adults. Emerging data also suggests that reductions in cerebral blood
flow (CBF) and brain volumes associated with depressive symptomatology are also linked to tau accumulation.
However, there have been no previous studies that have investigated the relationship of cortico-limbic tau
burden in MCI with more severe symptoms of depression, i.e., LLD. Further, nearly all extant studies
investigating tau deposition in neurodegenerative diseases of aging exclude both current major depression and
significant depression history. Evaluating individuals with chronic LLD is an important avenue to clarify the
relationships of tau with depressive symptomatology which would inform development of targeted interventions
for cognitive decline in older adults. Recent advances in Positron Emission Tomography (PET) radioligands with
high sensitivity and specificity to tau accumulation in limbic structures are ideally suited for this work. The goals
of this study are to: 1) Evaluate the association of depressive symptoms, and features of depression, with cortico-
limbic tau binding in a diverse sample of individuals with MCI; 2) Clarify the relative associations of depression
severity and tau deposition, in addition to brain volume, Aβ, CBF, and WMH with cognition at baseline; and 3)
Evaluate the relative association of baseline cortico-limbic tau and other neurobiological features (brain volume,
Aβ, CBF, WMH) with accelerated cognitive decline and course of depressive symptoms over 30 months. For the
proposed five-year study, 110 MCI participants with chronic LLD will be enrolled at the University of California -
San Francisco (UCSF) to obtain measures of regional [18F]-MK-6240 tau PET and florbetaben Aβ PET binding,
magnetic resonance imaging (MRI) measures of brain volume, CBF, and WMH, and genetic and clinical data.
Data from 165 MCI SSD and 165 MCI with no depressive symptoms (MCI ND) participants will be obtained from
the Alzheimer’s Disease Neuroimaging Initiative (ADNI-4) database for statistical analyses. We will use advanced
image harmonization methods to integrate imaging datasets and dissect patterns of neuropathology (Aβ and
tau), neurodegeneration, CBF, and WMH associated with depressive symptomatology and cognitive dysfunction.

Public health relevance
The overall goal of this study is to determine the association of cortico-limbic tau deposition with depressive symptomatology in individuals with concurrent Mild Cognitive Impairment (MCI). This will be done to clarify factors contributing to cognitive dysfunction and accelerated cognitive decline in these individuals at high risk for progression to dementia. The results of this study will inform the development of improved screening practices for identifying individuals with depressive symptoms who are at most risk for cognitive decline, facilitate the identification of new treatment targets for cognitive decline in older adults with depressive symptomatology, and inform to development of new and more effective intervention strategies and treatments for cognitive decline in older adults.